Development of an ELISA for serosurveillance of human hookworm

Hookworm infection, caused by Necator americanus, Ancylostoma duodenale, and Ancylostoma ceylanicum is
a leading cause of malnutrition and stunted growth in poor communities across sub-Saharan Africa, Asia, and
parts of South America. Recent studies have revealed the re-emergence of this parasite in the USA. The burden
of hookworm infection is generally associated with chronic illness rather than mortality in the host. Anemia,
stunted development, and intellectual and cognitive deficiencies are among the most serious outcomes of
persistent hookworm infections in children and women of reproductive age. In addition, chronic low-intensity
hookworm infection reduces vaccine efficacy and exacerbates other globally relevant infectious diseases such
as tuberculosis, malaria, and HIV, which are co-endemic with hookworm. Current strategies to control hookworm
rely primarily on the Mass Drug Administration of anthelminthic drugs. However, recent evidence calls into
question the long-term effectiveness of this approach to control and eliminate hookworm in endemic populations,
raising concern about the emergence of drug resistance. The current method to screen for STH infections is
microscopic demonstration and quantification of eggs in the stool. For screening, WHO considers the Kato-Katz
thick smear as a benchmark for diagnosing hookworm infection. This method, however, has poor sensitivity.
Processing multiple smears per sample or examining multiple samples over consecutive days can increase the
sensitivity of the Kato-Katz thick smear. While screening multiple samples improves sensitivity, it presents
considerable logistical and financial challenges and is not practical in all settings. To address this, WHO recently
published a Target Product Profile for soil-transmitted helminths to develop low-cost screening tools that meet
demands, currently not met by the Kato-Katz thick smear. To address this need, in Phase I we propose the
development of an ELISA to screen for human IgG against hookworm infection. In collaboration with Yale
University, we will perform a combination of in-silico and in-vitro studies, to help characterize biomarkers of
interest (Aim 1), which will be used in the development of an ELISA (Aim 2). We will then evaluate assay
performance (Aim 2) using well-characterized cohorts of serum samples. Our goal is to achieve sensitivity and
specificity as outlined in the TPP, with further improvement in Phase II. The proposed commercial ELISA kit will
allow for the replacement of the existing, relatively insensitive microscopic tools, to integrate as part of monitoring
and evaluation programs for hookworm infection around the world. This will directly impact future global policy
and strategy for the control of hookworm infection.

Public health relevance
PROJECT NARRATIVE Hookworm infection is a parasitic disease that causes significant morbidity in tropical and subtropical regions worldwide. The World Health Organization (WHO) has called for the development of new, low-cost tools for hookworm surveillance, to replace currently used methods which are laborious and low in sensitivity. In this project, we propose to develop a test for human antibodies to hookworm that will meet the requirements set forth by the WHO. In Phase II we will refine this assay to improve sensitivity and specificity, manufacture the product, and scale-up production.